Adaptations and Impacts Understanding Teen Pregnancy Prevention Programs

Modified Project Summary/Abstract Section
Adolescent pregnancies remain an area of marked health disparities. What there has
been significant effort put into the initial development and testing of evidence-based teen
pregnancy prevention programs (EBPs), little data exist to guide replication and
adaptation to local contexts or for different populations. Yet most EBPs require some
type of adaptation. This project combines mixed methods data from nine large-scale
federal- and state-funded replication projects with over 17,000 participants from various
locations and populations across the state of Indiana. The project seeks to advance our
understanding of adaptation in EBPs focused on four key areas: system involvement,
rural communities, use with different populations, and virtual approaches. Using the
Framework for Reporting Adaptations and Modifications-Expanded (FRAME) as a guide,
the specific aims of this proposal are: (1) to describe the frequency, characteristics and
type of adaptations made when implementing EBPs with a focus on the above four
areas; (2) to quantitatively examine the effect of adaptations in these four areas on key
EBP targets, including skills, knowledge, attitudes, intentions and behaviors, using youth
surveys; (3) to describe stakeholder’s approaches for determining the need for
adaptations in these four areas; and (4) to create an adaptation toolkit using a Delphi
process involving expert and community stakeholders. This project will inform EBP
adaptation and replication.

Public health relevance
Modified Public Health Relevance Section AIM-UP will combine data from nine large-scale teen pregnancy prevention projects to describe the use, examine the effectiveness, and describe approaches to adaptations of evidence-based programming for youth at high-risk for unintended pregnancy. Using the FRAME framework, the project examines adaptations in the following four areas: (1) system involvement; (2) use with different populations; (3) rural communities; and (4) virtual delivery. Effective adaptations will be translated into a toolkit using the Delphi approach for adapting evidence-based programs to local contexts.